Administration

Administration provides support to the basic science, clinical, population research, and education missions of the Cancer Center. Administrative support includes, but is not limited to, the following major activities: • Grants management administration and liaison functions with the University of Utah Office of Sponsored Projects • Space management and oversight of facilities (including glass wash), maintenance, equipment, and security • Shared Resources oversight and support regarding policies, recharge center activities, analysis, and audits • Oversight and control of HCI accounting and budgeting processes, including purchasing and receiving, payroll, accounts payable/receivables, general ledger, equipment inventory, financial reporting, financial policies, analysis, and internal controls • Administrative support for the Cancer Center Executive Director and Program Leaders • General Administration, including the Cancer Center Support Grant (CCSG) membership process, retreat planning and organization, seminar speakers, meeting scheduling and facilitation, as well as preparation of meeting minutes • Human Resources functions, including recruitment and annual investigator review process • In conjunction with respective Senior Directors, provide administrative and financial oversight of the Clinical Trials Office and High Risk Clinics and Registry • Computer network/phone support, data storage, security, and web services • Web services, communications, and public affairs, including news of Cancer Center research, discoveries, and patient care advances • Evaluation and strategic planning activities We request $105,397 for support of Center administration effort, 6.6% of the total CCSG budget request.